Mentored Patient-Oriented Research on Adolescent Alcohol Misuse and Treatment

PROJECT SUMMARY/ABSTRACT
This K24 midcareer research and mentoring program aims to provide the candidate with protected time from
direct patient care to conduct patient-oriented research (POR) on adolescent alcohol misuse and to mentor
early-career clinical investigators in translational research in addiction science. To meet the challenge of
advancing treatment options for the millions of American youth who struggle to reduce their alcohol use, the
field requires highly trained researchers who can integrate cutting-edge concepts and methods from a variety
of areas. As our understanding of addiction has become more complex, so too has the training needs of early-
career scientists. For more than two decades, the candidate has built a productive and continuously funded
POR program that translates theory-driven hypotheses from preclinical and human laboratory research to real
world applications. The proposed integrated plan will facilitate the candidate’s ability to mentor early-career
clinical investigators in POR and augment his capabilities as an independent clinician scientist. The research
plan, which focuses on improving treatment options for adolescent alcohol misuse through digital health,
dovetails the mentoring goals by providing a vehicle for mentoring early career scientists in: i) mechanisms of
alcohol use disorder pathogenesis and treatment effects, ii) clinical trial methods, iii) ecological momentary
assessment approaches, and iv) training in the responsible conduct of research. The candidate’s goal is to
further develop and refine an experimental therapeutics approach that yields high quality information to inform
decisions about whether further development of novel treatments is warranted. This K24 will support the
collection of pilot data for an integrative digital health platform based on gold standard psychosocial
interventions for treating AUD among adolescents. Adolescence is a critical period for the pathogenesis of
AUD. Alcohol use typically begins during adolescence and prevalence rates for AUD peak before age 21. Yet,
despite clinical demand, AUD treatments for youth rely on psychosocial interventions that yield only modest
benefits. One potential way to improve adolescent alcohol treatment is to augment the best available
psychosocial interventions with innovative digital health solutions.

Public health relevance
NARRATIVE Alcohol use typically begins during adolescence and prevalence rates for alcohol use disorder (AUD) peak before age 21. Yet, despite clinical demand, AUD treatments for youth rely on psychosocial interventions that yield only modest benefits at best. This K24 renewal will provide the candidate with protected time to mentor promising early-career scientists in patient-oriented research in alcohol science and conduct an innovative research project focused on leveraging digital health to improve access to evidence-based interventions.